COLONIC TRANSIT AND PELVIC FLOOR FUNCTION IN PATIENTS WITH CHRONIC CONSTIPATION

The purpose of this study is to investigate, utilizing both established and novel means, colonic transit and pelvic floor function in normal, and severely constipated individuals.